Imaging zinc secretion from the exocrine pancreas for the early diagnosis of pancreatic adenocarcinoma with MRI

ABSTRACT
This proposal aims to use noninvasive molecular magnetic resonance (MR) imaging of pancreatic zinc
content and secretion to detect pancreatic intraepithelial neoplasia (PanIN), as early pre-malignant pancreatic
ductal adenocarcinoma (PDAC) lesions. It is estimated that 55,440 people in the US will be diagnosed with
pancreatic cancer and 45,750 people will succumb to the disease in 2019. Current diagnostic techniques include
the use of imaging to localize a lesion and invasive biopsy sampling to stage the cancer and obtain molecular
and cellular information from the tumor. Once diagnosed, there are limited treatment options since symptomatic
patients will likely already have advanced stage PDAC. Therefore, there is a need to detect PDAC lesions early
and in a non-invasive manner. It is known that zinc is stored in zymogen granules in acinar cells at high levels
and that zinc homeostasis is uniquely dysregulated in PDAC. We have successfully demonstrated that MR
imaging with gadolinium (Gd)-based zinc sensors can report on zinc release from exocrine pancreatic tissue as
a response to caerulein stimulation. In this proposal we will evaluate a panel of secretagogues, which are
chemical compounds known to stimulate the secretion of zinc from ductal and/or acinar cells in the exocrine
pancreas, to optimize their ability to generate zinc flux detectable with our molecular MR probe. I will then use
this cell-specific metabolic zinc imaging technique to noninvasively quantify the zinc homeostatic dysregulation
in pancreatic cancer mouse models by MRI. Elucidating the role of zinc homeostasis in the development of
pancreatic adenocarcinoma by non-invasively measuring zinc release from acinar and ductal cells as a response
to their natural secretagogues will allow us to identify biomarkers that report on molecular transformations early
in the disease. This in turn could then enable patients to obtain a diagnosis at an early stage and thus have
access to more effective therapies and curative surgical options.
The short-term goal of this project is to optimize and characterize the stimulated zinc secretion in the
exocrine pancreas and its detection in vivo with molecular MRI to identify early malignant transformations in
PDAC, in doing so I will obtain the training from my advisory committee, who are experts in the field of pancreatic
cancer molecular pathogenesis, histopathology, surgery, and radiology. Attaining my short-term goal will enable
me to obtain expertise in the following areas: 1) Clinical pathology techniques for diagnosis of pancreatic
adenocarcinoma. 2) Biomarker identification and validation. 3) Metabolic implications of zinc homeostasis in
PDAC pathogenesis. This project will also allow me to generate data that will enhance my probability of success
in obtaining independent NIH grant support. With the skills and knowledge obtained because of the research
and training activities from this proposal, I will be able to reach my long-term goal of becoming an independent
translational investigator using MRI to infer key metabolic, biological, and physiological characteristics of cancer
pathogenesis based on metal homeostasis.

Public health relevance
PROJECT NARRATIVE Pancreatic cancer is ranked as the fourth leading cause of cancer-related death in the United States with 1 - and 5-year survival rates of 20% and 7%, respectively. It is known that in pancreatic cancer zinc storage and transport is dysregulated, and that the level of dysregulation follows malignant progression. This work proposes a non-invasive technique to detect early malignant transformations in pancreatic cancer using a MRI zinc sensor. This approach based on MR imaging of zinc content and secretion places this proposal in a unique position to revolutionize the diagnostic paradigm of pancreatic cancer in the clinic.